Leadership Administrative Core

The Leadership Administrative Core (LAC) is responsible for the organizational, communication and regulatory functions of the Pittsburgh Pepper OAIC. The LAC receives valuable input and direction from 4 advisory groups including 1) the External Advisory Committee, 2) the Institutional Advisory Board, 3) the Community Advisory Board and 4) the RCDC Advisory Committee. These complementary advisory boards provide advice and insight to the OAIC Executive Committee composed of our core leaders. Our specific aims are to: 1. Foster communication and multidisciplinary collaboration among OAIC investigators, cores and projects. 2. Promote increased attention and involvement in our work with relevant investigators and research programs in and outside the University of Pittsburgh. 3. Represent the OAIC to the University through an Institutional and Community Advisory Boards. 4. Represent the OAIC to other OAICs, the larger academic, NIH, clinical and lay communities. 5. Through the External Advisory Committee, maintain independent oversight of OAIC processes, resources and progress toward goals. 6. Through the External Advisory Committee and ad hoc reviewers, provide independent oversight to the pilot, developmental projects and Pepper KL2 Scholar programs. 7. Through the RCDC Advisory Committee provide oversight for the RCDC KL2 Scholars program. 8. Establish and operate a Safety Monitoring Board for all OAIC human studies. 9. Sponsor a Research Seminar series, an Annual Retreat, a Visiting Professor Series, Workgroups, publication/communication committee, formal grant reviews, and new partnership initiatives. 10. Increase basic and translational research partnerships. 11. Maintain meticulous financial records. 12. Provide administrative support and oversight for the RCDC, PESC and three research cores. 13. Promote quality and timeliness in all OAIC activities. 14. Collaborate outside the Institution for OAIC related themes. For the renewal, we plan five programmatic changes. First, our RCDC will be restructured into a KL2 format. Second, we have revised our seminar series to include complimentary experts representing basic and clinical scientists focused on mobility and balance. Third, we will begin a Leadership Skills Workgroup designed to foster leadership skills. Fourth, we are enriching our Biology of Mobility/Aging work group with nationally known scientists focused on our theme. Fifth, we will promote grant partnerships and leveraging of resources from internal and external resources.